Neuromodulation in the striatum

PROJECT SUMMARY
The striatum serves as the entry station of the basal ganglia. It mediates many critical brain functions, including
motor control, decision making, learning, and reward. In particular, the dorsolateral striatum plays essential roles
in locomotion execution and motor learning. The striatum outputs to two distinct pathways: a direct pathway that
directly innervates the output nuclei of the basal ganglia, and an indirect pathway that projects to the basal
ganglia output nuclei indirectly via related nuclei. These two pathways form a push-and-pull system, with the
direct pathway promoting movement initiation, and the indirect pathway inhibiting movement. The balance of the
push-and-pull system is critical to proper motor execution, and defective balance is associated with neurological
disorders, such as Parkinson’s disease and Huntington’s disease.
The balance of the two pathways is tightly regulated by neuromodulators. Dopamine is the most studied
neuromodulator in the striatum. Locomotion intention is associated with increased dopamine release in the
striatum. Dopamine enhances the direct pathway function by upregulate intracellular cAMP concentrations and
the function of cAMP-dependent kinase in the projection neurons of this pathway, while suppressing the other
pathway by inhibiting cAMP and cAMP-dependent kinase in the projection neurons of the indirect pathway.
However, dopamine is not the only neuromodulator in the striatum. Other neuromodulators, such as adenosine,
are also known to play roles in the striatum. Adenosine receptors are abundantly expressed in the striatum.
However, it is not known whether and when adenosine is released during animal behavior, how it affects
intracellular cAMP and cAMP-dependent kinase in the projection neurons of the two pathways, and how such
effects mediate animal locomotion. Our proposal aims to answer these questions by using modern imaging or
optical measurements of the activities of both extracellular adenosine concentrations and the cell type-specific
activity of intracellular cAMP-dependent kinases in behaving mice during locomotion. Our results will add a
previously underexplored dimension to the knowledge of neuromodulation in the striatum, which may deepen
our understanding of the striatal function and dysfunction.

Public health relevance
PROJECT NARRATIVE The striatum is a brain structure that plays an essential role in action control, reward and decision making, and its dysfunction is associated with neuropsychiatric disorders. We aim to employ modern optical measurement technologies to visualize and investigate the precise neuromodulator releases and subcellular signaling events involved in locomotion in behaving mice. We expect that our study will lead to a deeper understanding of neuromodulatory mechanisms underlying striatal function and locomotion control, which will in turn lead to an increased understanding of neuropsychiatric diseases associated with striatal dysfunction.